Engineered nanoparticles to control inflammation and fibrosis after acute myocardial infarction

Program Director/Principal Investigator (Last, First, Middle): GUAN, JIANJUN
Project Summary
Following myocardial infarction (MI, or heart attack), the prolonged inflammation due to delayed transition of
proinflammatory phase to anti-inflammatory phase, and uncontrolled cardiac fibrosis following myofibroblast
differentiation, deteriorate cardiac function. As such, timely transitioning the proinflammatory phase to the anti-
inflammatory phase, and inhibiting myofibroblast formation will improve cardiac function. However, the effective
therapies to simultaneously achieve both goals remain to be established. Currently, systemic delivery of anti-
inflammatory agents did not show consistent outcomes in clinical trials, mainly because the drugs either inhibit cardiac
repair or are not delivered in a spatiotemporal manner to effectively target specific inflammatory signals. To attenuate
cardiac fibrosis, systemic delivery of TGFβ inhibitors and antibodies represents a major strategy. Yet, the efficacy is
not satisfactory because these therapies cannot essentially inhibit TGFβ pathway, and also cannot simultaneously
prevent other major pathways-induced myofibroblast formation, e.g., IL-1 pathway.
In this project, we propose a new approach to address the above limitations. We will directly deliver, at acute MI
stage, secretome of M2 macrophages (M2Mφs), a dominated cell type in the anti-inflammatory phase, to timely
decrease inflammation in the infarcted hearts. Besides anti-inflammation function, we found that M2Mφ-secretome
increases cardiac cell survival and promotes angiogenesis in the infarcted hearts. Thus, it is multifunctional. Yet,
M2Mφ-secretome has not been explored for cardiac therapy before.
To prevent cardiac fibrosis, we propose to deliver a newly synthesized, peptide-based inhibitor RPE that
simultaneously inhibits TGFβ and IL-1 pathways-induced myofibroblast differentiation. Our preliminary studies
demonstrate that RPE significantly reduced myofibroblast density in the infarcted hearts. To the best of our knowledge,
there is no known inhibitors that simultaneously inhibit these 2 pathways.
To deliver the M2Mφ-secretome and RPE into infarcted hearts at the critical time window to attenuate inflammation
and myofibroblast formation - acute MI stage, while considering that direct myocardial injection has safety concerns
at this stage, we will deliver them by IV injection, after encapsulating them into infarcted heart-targeting nanoparticles.
These nanoparticles will specifically accumulate in infarcted hearts following IV injection. They will then
spatiotemporally release M2Mφ-secretome and RPE.
We hypothesize that IV delivery of infarcted heart-targeting nanoparticles capable of releasing M2Mφ-secretome,
and RPE at the acute MI stage will efficiently decrease tissue inflammation, increase cardiac cell survival, promote
angiogenesis, and attenuate cardiac fibrosis, leading to a significant increase of cardiac function.
AIM 1 will test the hypothesis that optimal M2Mφ-secretome composition will efficiently decrease cell
proinflammatory cytokine secretion, improve cardiac cell survival under ischemia, and promote endothelial cell
morphogenesis. AIM 2 will test the hypothesis that optimal RPE release profiles will simultaneously prevent TGFβ and
IL-1 pathways-induced cardiac fibroblast differentiation into myofibroblast. AIM 3 will test efficacy of the M2Mφ-
secretome and RPE releasing nanoparticles delivered at different times in the acute MI stage.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): GUAN, JIANJUN Project Narrative: Following myocardial infarction, the prolonged inflammation and uncontrolled cardiac fibrosis gradually deteriorate cardiac function. Thus, timely transitioning the proinflammatory phase to anti-inflammatory phase, and inhibiting cardiac fibrosis are crucial for improving cardiac function. However, the effective therapies to simultaneously achieve both goals remain to be established. This project will create and validate a conceptually new approach to address current limitations. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page